Modeling and modulating neural responses to reward and threat: Associations with childhood adversity and risk for substance use problems

PROJECT SUMMARY/ABSTRACT
This K23 proposal seeks to provide an early-career clinical psychologist (Dr. Katherine McCurry) with the
mentorship, training, and resources necessary to launch a career as an independent patient-oriented
investigator focused on affective neuroscience, multivariate predictive modeling, and neuromodulatory
approaches to personalized prevention and early intervention for substance use disorders (SUDs). Childhood
trauma is associated with earlier initiation of substance use, faster progression to heavy drinking during
adolescence, and increased risk of SUDs in emerging adulthood, making early intervention critical for reducing
the burden of SUDs in trauma-exposed youth. However, significant heterogeneity in traumatic experiences
may result in differential neurodevelopmental impacts and may hamper the development of efficacious
interventions. Translational neuroscience provides a valuable framework for leveraging links between
childhood trauma and developmental processes implicated in SUD to design and test targeted interventions.
The dimensional threat-deprivation model posits, in part, that deprivation experiences (e.g., neglect) may lead
to blunted behavioral and striatal responses to reward, while threat-related experiences (e.g., abuse), may lead
to heightened vigilance and exaggerated amygdalar reactivity towards potential threats. However, to date, the
influence of trauma type on the complex distributed networks involved in reward- and threat-processing has not
been investigated within the same developmental sample. Identifying predictive multivariate neurosignatures
will provide insight into the distinct and shared neurodevelopmental mechanisms underlying childhood
trauma’s associations with substance use and inform novel targeted intervention strategies. Of specific interest
is real-time functional magnetic resonance imaging neurofeedback (rtfMRI-nf), a promising technique that aims
to facilitate learning by providing an individual with real-time information about their brain state. In the proposed
project, the Candidate will conduct research using neuroimaging data from a large-scale developmental study
(i.e., the Adolescent Brain Cognitive Development [ABCD] Study®) and collect pilot rtfMRI-nf data from 50
adolescents (aged 13-16; 50% female) to address the following research aims: 1) Identify reward and threat-
related multivariate neurosignatures predictive of problematic substance use in adolescence; 2)
Elucidate specificity of links between traumatic experiences (i.e., deprivation versus threat), aberrant
neurosignatures (reward-related and threat-related circuits), and problematic substance use; and 3)
Assess adolescents’ ability to modulate reward and threat-related multivariate neurosignatures using
real-time fMRI neurofeedback. Completion of specialized training in 1) neurodevelopmental risk trajectories
for SUD; 2) multivariate predictive analytics for large neuroimaging datasets; 3) rtfMRI-nf design, execution,
and analysis; and 4) clinical trial design and analysis will ensure the Candidate’s success in achieving the
proposed research aims and establishing herself as an independent translational scientist.

Public health relevance
PROJECT GOALS/NARRATIVE Childhood trauma is associated with a significantly increased risk of substance use disorders (SUDs), but the neurodevelopmental mechanisms by which different types of trauma may impact risk trajectories for SUDs are not well understood. The proposed project seeks to address this gap by providing an early-career scientist with the tools and training necessary to examine the links between reward and threat-related multivariate neurosignatures, childhood traumatic experiences, and problematic substance use in adolescence. Findings from this work may provide a foundation for future design and testing of targeted neuroscience-informed interventions for trauma-exposed youth at risk of SUDs.